Catalytically Generated Amidyl Radicals for Site-Selective Intermolecular C-H Functionalization

Project Summary
The selective activation and functionalization of C–H bonds is one of the most important and challenging
chemical transformations. The ability to activate any targeted C–H bond in a given molecule would immensely
expand the scope of synthetically accessible chemical transformations and would be a powerful method of late-
stage functionalization of complex molecules such pharmaceuticals, natural products, and commodity chemicals.
Furthermore, carrying out these reactions using abundant, non-toxic catalysts and renewable energy sources
(e.g., solar energy) is critical for the development of sustainable chemical processes. Achieving selectivity in C–
H activation is often difficult due to the presence of numerous C–H bonds of similar strength in a given molecule.
Even more challenging is discriminately functionalizing strong C–H bonds in proximity to weaker C–H bonds.
Selectivity for C–H activation is often dictated by properties of the substrate, and in such cases, reactivity may
be limited to the weakest or most acidic C–H bond. However, catalyst-control of selectivity, wherein the structure
of the H-atom abstractor dictates selectivity, offers a powerful method of predictably introducing chemical
diversity from hydrocarbon feedstocks. Amidyl radicals are potent H-atom abstractors (BDE(N–H) > 100 kcal
mol-1) that are capable of cleaving strong C–H bonds, but their applications in intermolecular C–H activation
reactions often rely on pre-functionalized amidyl sources, rendering them stoichiometric reagents. The direct
activation of amide N–H bonds to generate amidyl radicals would provide catalytic access to these reactive
intermediates and would dramatically improve their utility in C–H functionalization reactions. This proposed
research strategy aims to develop new electro- and photocatalytic methods for direct N–H bond activation via
proton-coupled electron transfer to generate amidyl radicals for selective C–H activation. By exploiting these
modes of N–H bond activation in sterically shielded amide catalysts, the steric pressures imposed the amidyl
radicals can dictate site-selectivity. A combination of electrochemical kinetics and photophysical studies,
including time-resolved transient absorption spectroscopy and photocrystallography, will be employed to
delineate the key structural and electronic features that govern selectivity. Overall, these studies will expand our
ability to perform catalytic, site-selective C–H functionalization reactivity using sustainable energy sources.

Public health relevance
Project Narrative The ability to selectively functionalize C–H bonds enables synthetic access to a wide range of valuable chemical feedstocks for the production of pharmaceuticals, natural products, polymers, and commodity chemicals. A promising strategy to carry out selective hydrocarbon functionalization is to design modular catalysts in which the steric and electronic constraints of the active site impart catalyst-encoded selectivity towards a targeted C– H bond. This work aims to harness the oxidative power of electro- and photochemically generated nitrogen- centered radicals catalysts for selective C–H bond functionalization.